BACK-TRANSPORT OF INFANTS--EFFECTS ON FEEDINGS AND OXYGENATION

A case control investigation of infants back transported by ground ambulance to determine if infants have any feedings intolerances and/or oxygenation disturbances in the first 24 hours following transport.